Evaluation of Developmental Toxicity, Neurotoxicity, and Internal Dosing/Chemical Analysis of 92 Compounds in Zebrafish (TGMX 0004)

Evaluation of Developmental Toxicity, Neurotoxicity, and Internal Dosing/Chemical Analysis of 92 Compounds in Zebrafish Keywords: zebrafish, toxicity, alternative model, Neurotoxicity, Developmental toxicity